Research Experience & Training Coordination Core

Summary/Abstract: The Center for Leadership in Environmental Awareness and Research (CLEAR) seeks to prepare the next generation of leaders to effectively address complex environmental health problems, particularly the impact of vapor intrusion of volatile organic compounds (VOCs) on preterm birth and associated adverse health outcomes in post-industrial urban settings, through professional careers in the environmental and/or biomedical sciences. The preparation of skilled transdisciplinary, team-scientists requires a systems approach that integrates a range of disciplines, stakeholders, and experiential learning opportunities. Building on Wayne State University’s (WSU) strength as an urban R1 institution the Research Engagement and Training Coordination Core (RETCC) will coordinate, problem-based, solution-oriented research experiences and training. In Aim 1, RETCC will promote a systems approach to transdisciplinary training for a motivated group of graduate students and postdoctoral fellows by promoting the use of an individualized development planning (IDP) system to integrate planning, monitoring, and feedback across a range of experiential learning opportunities based on trainee professional goals and guided by our transdisciplinary competency model; supporting interdisciplinary problem-solving by integrating a range of student pipelines and developing skills in mentoring excellence; leveraging interdisciplinary graduate courses taught by CLEAR faculty to provide trainees with a Graduate Certificate in Urban Environmental Health; and collaborating with CLEAR project leaders to provide trainees with cross-disciplinary, hands-on field and laboratory research opportunities. In Aim 2, RETCC will coordinate interactive, collaborative, problem-based training opportunities with the Data Management & Analysis Core (DMAC) to offer solution-oriented interactive summer workshops as well as data sharing opportunities and access to DMAC facilities and expertise. In Aim 3, RETCC will facilitate trainees’ ability to generate and apply scientific knowledge in ways that effectively engage stakeholders and communities, and to translate scientific knowledge to inform policy-making and support environmental health through micro-internship opportunities with the Community Engagement Core and the Administrative Core’s Research Translation function. Aim 4 is focused on enriching career and leadership development of CLEAR trainees, through a CLEAR Leadership Fellowship program to support leadership development in grant and budget management, leading interdisciplinary teams, and enhancing their national profile as emerging environmental health science leaders through trainee-led invited speaker series and virtual knowledge exchanges with other Superfund trainees across the country. RETCC will also provide funding to support scientific conference travel and pilot studies that incorporate collaborations across disciplines and stakeholders, and coordinate access to WSU state-of-the-art core facilities, expertise, and mentoring.

Public health relevance
Project Narrative The Center for Leadership in Environmental Awareness and Research (CLEAR) proposes an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposure routes and health risks from volatile organic compounds (VOCs) in urban areas. The Research Experience and Training Coordination Core (RETCC) takes a systemic approach to respond to SRP’s strategic mandates by supporting holistic career development for trainees through transdisciplinary, experiential leadership opportunities and plays a central role in preparing the next generation of leaders in the environmental and/or biomedical sciences to address complex environmental health problems.